Animal MRI/Imaging Facility

The Animal MRI Facility has performed MRI studies, data analysis, and/or manuscript preparation input on the following projects from Oct. 1, 2020 to Sept 01, 2021. Projects are listed alphabetically by Principal Investigator: 1. Elinoff, CC. Pulmonary hypertension (PH) rat model treatment study. 2. Kopp, J. NIDDK. Exploratory imaging of fetal mice in utero. 3. Kozel, NHLBI. Imaging aortic wall characteristics in a mutant mouse model with abnormal elastin. In vivo and ex vivo imaging, elastin-specific contrast was applied to two mouse models with blood vessel abnormalities. 4. Moss, J. NHLBI. Cardiac imaging to phenotype mouse mutant strains.